Sinorhizobium meliloti factors that affect biofilm formation and symbiosis efficiency

Project Summary / Abstract
The proposed project will elucidate the mechanisms that control polar adhesin production, biofilm
formation, and host colonization in alpha-proteobacteria, a physiologically heterogeneous group that includes a
number of significant human pathogens. Particularly relevant to public health, biofilm formation plays a crucial
role in the survival of bacteria in diverse environments: cells in biofilms attach recalcitrantly to biotic and abiotic
surfaces, develop increased resistance to antimicrobial agents, and contribute to persistent infections.
Although limiting biofilm formation has the potential to prevent and restrict microbial diseases, little is known
about biofilm formation by alpha-proteobacteria and how it facilitates host colonization.
We previously discovered a biofilm-associated mutation common in laboratory strains of Sinorhizobium
meliloti, a model alpha-proteobacterium that forms mutualistic symbiosis with compatible legumes by
colonizing root tissues and fixing nitrogen in exchange for nutrients from plant hosts. Correcting the mutation
restored full-length production of the conserved polarity factor PodJ, thus enabling synthesis of the holdfast (a
polar adhesin) and assembly of robust biofilms, phenotypes never observed before. We found that biofilm-
competent strains possess a competitive advantage over biofilm-deficient strains during host infection. Via
transposon mutagenesis, we identified a number of genes involved in biofilm development, including one
encoding a conserved transcription factor (LdtR) and another encoding a diguanylate cyclase and
phosphodiesterase, known to modulate levels of the c-di-GMP second messenger. The goals of this proposal
are (a) to decipher the responsibilities of key regulators during biofilm formation and host colonization and (b)
to establish a system for monitoring the relationship between symbiosis and environmental factors. We plan to
achieve these goals by accomplishing the following three specific aims. (1) We will determine how LdtR
expression is regulated and what cellular functions it performs. (2) We will assess how factors that modulate c-
di-GMP levels contribute to biofilm formation and host infection. (3) We will evaluate whether symbiosis affects
host response to toxic compounds and how chemical stress and other microbes influence host-symbiont
interactions. Results from the investigation will provide a better model of how cellular and external factors can
contribute to adhesion, biofilm formation, and host invasion in alpha-proteobacteria.
In addition to accomplishing the scientific objectives described above, funding of this proposal will
enhance the research productivity and grant competitiveness of the investigator and allow students, particularly
those from underrepresented backgrounds, to gain research training and preparation for biomedical careers.

Public health relevance
Project Narrative The proposed research aims to examine factors that influence how bacterial cells infect and colonize their host organisms. Results from the investigation will provide insights into microbe- host interactions, both beneficial and harmful, and ultimately improve the prevention and treatment of microbial diseases. In addition, the project will provide immersive research experiences for students, particularly those from traditionally underrepresented backgrounds, and encourage their pursuits of biomedical careers, thus enhancing the diversity of the workforce pipeline in health-related fields.